Mid-Career Development and Mentoring on Financial Vulnerability and Alzheimer's Disease

PROJECT SUMMARY/ABSTRACT
Understanding financial exploitation among older adults is an important public health issue; however, the
reasons why some older adults may be more susceptible to fraud are poorly understood. To address this, I
have developed a program of research focused on understanding the diverse behavioral, contextual, and
neurobiological factors that impact financial decision making and financial exploitation vulnerability in older
age. This program of research leverages extramurally-funded USC-based resources and collaborative
endeavors with the Rush Alzheimer’s Disease Center (RADC), which together provide trainees the opportunity
to work with diverse datasets and research mentors. Age-related decline in cognitive abilities impacting
financial decision making is believed to be a central risk factor for fraud in older age. Those with Alzheimer’s
Disease and Related Dementias (ADRD) and Mild Cognitive Impairment (MCI) are believed to be most at risk
for financial exploitation. However, most of this research is based either on indirect or anecdotal evidence.
Relatedly, cognitive symptom profiles of those with ADRD who experience scam and fraud are unknown.
Neuroimaging work has implicated the structure and connectivity of specific brain regions as neurobiological
mechanisms; however, these have yet to be implicated in ADRD patients specifically. Importantly, since factors
associated with Alzheimer’s Disease are known to differ by race, and rates of financial fraud appear to differ
according to race, an understanding of these differences is a scientifically crucial. To address these questions,
the research project for this K24 Career Development Award proposes to expand the current program of
research by investigating the associations between financial fraud and ADRD in the Health and Retirement
Study (HRS) and the Rush Alzheimer’s Disease Center (RADC) cohorts. The HRS is considered the largest
and most nationally-representative study of aging in the United States. In 2016, the HRS initiated Module 2,
which introduced financial fraud items into the survey. Since 2013, the RADC has collected financial decision
making and neuroimaging data as an integrated part of their large, community-based, neuroepidemiologic
studies of aging, and I have been an active collaborator on many of these studies. A proposed mentoring team
consisting of USC and RADC faculty will provide me and my mentees guidance in mentorship, professional
development, and current research approaches in the HRS and RADC cohorts. Finally, because financial
vulnerability in non-demented older adults has recently been associated with greater risk for Alzheimer’s
Disease in longitudinal models, we secondarily aim to explore the association of preclinical Alzheimer’s
Disease blood-based biomarkers with financial exploitation risk in a subset of local older adults without
cognitive impairment. This mid-career award will address financial vulnerability considerations in ADRD.

Public health relevance
PROJECT NARRATIVE This K24 Mid-Career Development Award proposes to expand our current program of research by investigating the associations between financial fraud and Alzheimer’s Disease and Related Dementias (ADRD) in the Health and Retirement Study (HRS) and the Rush Alzheimer’s Disease Center (RADC) cohorts. A mentoring team consisting of USC and RADC faculty will provide the PI and trainees guidance in mentorship, professional development, and current research approaches with large datasets. Trainees will be provided with a wide range of research opportunities focused on financial vulnerability and cognitive/behavioral considerations in ADRD research.